An Automated Multimodal, Multiscale Algorithm for Cervical Cancer Screening in Low- and Middle-Income Countries

PROJECT SUMMARY/ABSTRACT
Cervical cancer is responsible for the deaths of over 300,000 women per year. An estimated 90% of the deaths
occur in low- and middle-income countries (LMICs). Due to the limited access to healthcare facilities in LMICs
and time required for staining a specimen and receiving pathology confirmation of a diagnosis, the WHO
recommends screening with an HPV DNA test followed by triage and further treatment in a single visit. Multimodal
cervical imaging integrated with deep learning algorithms can serve as an automated, reproducible, and scalable
triage test that provides a real-time highly sensitive and highly specific diagnostic result in LMICs, where there
may be a lack of trained clinicians and pathologists. The Richards-Kortum lab has developed a low-cost
multimodal colposcope that captures microscopic and macroscopic images of the cervix in a clinical setting.
Building on these hardware developments, the deep learning-based diagnostic test will be designed by pursuing
the following three specific aims: 1) Design a multimodal image registration algorithm to spatially correlate and
combine information from widefield colposcope images of the cervix, that are acquired after staining with each
of two common standard of care solutions (acetic acid and Lugol’s iodine), and HRME images. 2) Develop a
deep learning algorithm that integrates spatiotemporal information across a sequence of HRME video frames
and predicts cervical cancer diagnosis in real-time. 3) Evaluate clinical performance of the algorithms using an
available dataset of images collected from patients at two different low-resource setting clinical sites in Brazil.
This project benefits greatly from the co-mentorship offered by Dr. Rebecca Richards-Kortum and her colleague
Dr. Kathleen Schmeler, who both have extensive experience in cervical cancer prevention for low-resource
settings. Dr. Richards-Kortum has led many projects involving the development of low-cost biomedical optical
imaging technologies and their associated algorithms. Dr. Schmeler has led efforts to enable integration of these
technologies into clinical workflows. The training plan and environment at Rice University and Baylor College of
Medicine have been specifically tailored for my interests in deep learning, biomedical optical imaging, clinical
translation, and global health. My training involves receiving guidance and feedback from experts in deep
learning for biomedical applications as I develop the proposed algorithms, attending workshops, presenting at
imaging and global health conferences, teaching and mentoring trainees, and pursuing translational research
aims to ensure success in my proposed research. Overall, my proposed research and training plan aligns
perfectly with my goal of becoming a physician-scientist in the field of obstetrics & gynecology. As a physician-
scientist, I hope to continue working on the development of biomedical imaging technologies for cancer screening
and facilitate the integration of these technologies into the clinical care I provide for underprivileged communities.

Public health relevance
PROJECT NARRATIVE Cervical cancer is a life-threatening disease that is associated with microscopic and macroscopic changes in the cervix, such as the development of lesions, and disproportionately affects low- and middle- income countries. A major barrier in implementing and sustaining screening programs for cervical cancer in low-resource countries is the lack of trained clinicians. This proposal will develop and evaluate a novel multimodal, multiscale deep learning algorithm workflow that integrates microscopic and macroscopic features from cervical images to automatically arrive at a diagnostic result, which could improve access to cervical cancer screening and significantly decrease mortality due to the disease.